Genomic regulation in ERF-related craniosynostosis

One of the most common craniofacial birth defects is craniosynostosis (CS), where connective tissue of
the sutures that normally separate skull bones is prematurely replaced by bone. While most CS cases
are of unknown origin, about 20% can be attributed to single gene mutations. Among these,
heterozygous inactivating mutations in ERF cause CS of variable severity, affecting multiple sutures
and sometimes manifesting later in childhood. Erf is an ETS2-related transcription factor (TF), but
unlike most family members is a transcriptional repressor. It is thought to compete with activating ETS2
factors for binding to the consensus site GGAA and prevent induction of target genes. Despite
widespread expression of ERF and the critical role that ETS2 signaling plays in normal development,
haploinsufficiency for ERF leads to a very limited set of defects. Our proposal is aimed at discovering
the underlying mechanisms leading to CS in a setting of reduced Erf. We have created a zebrafish erf
mutant which displays severe multi–sutural CS, demonstrating deep conservation of the role of Erf in
normal skull development. We previously identified three enhancers from the human genome which
direct expression to skeletal precursor cells in transgenic zebrafish, two associated with RUNX2 and
one with BMPER, that bind ERF in a yeast 1–hybrid assay. Both genes are independently implicated in
CS risk, suggesting that their increased expression in ERF mutants contributes to the pathogenesis of
CS. We propose to test specific hypotheses about the pathogenesis of CS caused by Erf reduction. In
Aim 1, we will use live imaging to follow the progression of CS in erf mutant fish. We will determine the
growth rate of the skull bones before and after suture formation, the timing of suture fusion, and how
variable the process is among mutants. These data will allow us to distinguish among models of CS
pathogenesis and focus our epigenomic profiling at the appropriate stages. In Aim 2 we will assess
genome–wide changes in accessible chromatin and gene transcription in erf mutants during
craniofacial development. We hypothesize that CS in erf mutants results from increased expression of
a small number of critical genes. By correlating open chromatin regions containing Erf binding sites with
upregulated genes in the erf mutants, we aim to identify critical genes that are direct targets of Erf
regulation. Finally, in Aim 3 we will test the hypothesis that loss of Erf results in increased expression, of
RUNX2 and BMPER and of additional candidate genes implicated in Aim 2, by determining the activity
of identified enhancers in erf mutants. We will characterize the timing and tissue specificity of enhancer
activities and quantify changes in expression in erf mutants. Successful completion of our Aims will
provide detailed insight into the genetic and cellular mechanisms underlying craniosynostosis in the
setting of reduced Erf and the conserved role of Erf in normal craniofacial development.

Public health relevance
Craniosynostosis, premature fusion of skull bones, is one of the most common human craniofacial birth defects. We have created a zebrafish model for one of the genetic defects that causes craniosynostosis in humans, and through study of the zebrafish, aim to better understand the genetic and cellular events that lead to defective skull development. Our findings will aid in providing better counseling to families and in developing more targeted therapies for these patients.